Role of cytosolic DNA-induced sterile inflammation driving cellular and organismal progeria/aging hallmarks

Abstract
Accumulation of cytosolic DNAs has emerged as a new hallmark of aging that triggers sterile inflammation and
contributes to tissue deterioration. However, the mechanisms that generate cytosolic DNAs or the signaling
whereby they contribute to aging remain poorly understood. In Hutchinson-Gilford Progeria Syndrome (HGPS),
caused by a LMNA gene mutation that encodes a truncated lamin A named “progerin”, we find build-up of
cytosolic DNAs, concomitant with profound genomic instability and sterile inflammation. The goal of this proposal
is to determine whether this persistent sterile inflammation, which includes an interferon (IFN) response and a
senescence-like secretory phenotype, drives metabolic dysfunction and tissue degeneration in progeria, and to
define the mechanisms involved. Deciphering the mechanisms controlling sterile inflammation in aging/progeria
will provide novel strategies to improve healthy aging and reduce the severity of diseases like HGPS.
Our in vitro and in vivo data show that STING and STAT1 drive progeroid phenotypes. Indeed, pharmacological,
or genetic inhibition of STING and STAT1 repressed sterile inflammation and improved cellular hallmarks of
aging and, critically, targeting STAT1 increased the healthspan and the lifespan of progeria mice. Yet, the
molecular mechanisms whereby progerin engages STING and STAT1 activities, and the roles played by STING
and STAT1 triggering metabolic alterations and tissue degeneration in progeria are unknown. Unexpectedly, our
data also show that progerin does not trigger the canonical cGAMP-dependent mode of STING-STAT1 pathway
activation. This proposal aims to define the non-canonical mode of STING stimulation upon progerin-induced
accumulation of cytosolic DNAs (Aim 1), the role that STING, STAT1, and downstream interferon stimulated
genes such as ISG15 play driving cellular metabolic alterations (Aim 2), and the contribution of STING-STAT1-
ISG15 pathway to tissue degeneration/loss and reduced healthspan and lifespan of progeria mice (Aim 3).
If successful, our studies will demonstrate that a fundamental mechanism driving progeria is the maladaptive
response to nuclear/mitochondrial damage and accumulation of cytosolic DNAs, which lead to a sustained and
unresolved sterile inflammation/IFN response that compromises metabolism and tissue homeostasis.
Demonstrating that cytosolic DNA-triggered pathways drive metabolic dysfunction and tissue loss in progeria,
defining the mechanisms involved, and showing that targeting specific factors in the pathway in vivo has
beneficial effects, will have important and potentially transformative therapeutic implications for this devastating
and uncurable disease, which will likely be relevant to metabolic phenotypes during normal aging.

Public health relevance
Project narrative The goal of this proposal is to define a role for cytosolic DNAs triggering metabolic alterations and tissue degeneration in progeria through a sterile inflammation/interferon (IFN) response driven by a non-canonical STING-STAT1 pathway. The central hypothesis is that metabolic and tissue loss phenotypes of HGPS are the result of a maladaptive response to nuclear and mitochondrial damage and build-up of cytosolic DNAs, which trigger a sustained and unresolved IFN response that hinders tissue homeostasis.